A Novel Device for Uterine Hemostasis Post Cesarean Section

Project Summary
Cesarean sections are the most common surgery in the world. In the US alone, 3,000 are performed each day.
Postpartum hemorrhage (PPH) remains the leading cause of preventable maternal mortality worldwide,
accounting for 27% of the 295,000 maternal deaths worldwide, and 11% of maternal deaths in the United
States. PPH is also the leading cause of severe maternal morbidity, resulting in both short and long-term
consequences to a new mother’s physical and psychological health. Despite efforts at reduction, the rates of
PPH increased by 13% in the US between 2010 and 2014 with atony-related hemorrhage, when the uterus
fails to contract after birth, accounting for 80% of cases. The vast majority of these cases are deemed
preventable. In the US, data shows that black women have significantly higher rates of severe mortality and
morbidity associated with PPH – contributing to a widening health disparity. Compared to vaginal birth,
women undergoing cesarean delivery incur the highest risk of PPH, hemorrhage-related morbidity, and cost to
the healthcare system. Prophylactic administration of oxytocin has been shown to reduce the incidence of PPH
by 50- 60%, however, there are not clear recommendations for oxytocin dosing regimens and the most
appropriate approach to prophylactic dosing at CD continues to be actively investigated as larger doses may
be required but there can be significant hemodynamic changes after IV boluses of oxytocin. Adverse effects
such as ST segment depression, hypotension and tachycardia are well recognized, and have been implicated
as a contributory cause of maternal death. Also, studies have demonstrated that prolonged use of oxytocin
during induction of labor or augmentation can decrease the effectiveness of this measure. When AMTSL
measures fail to control bleeding, therapeutic options include administration of additional uterotonics, uterine
balloon tamponade, invasive uterine artery embolization, uterine compression sutures, and hysterectomy are
employed. Recently, a multi-center randomized control trial using tranexamic acid failed to demonstrate
significance in preventing postpartum hemorrhage in 11,000 patients. A novel method to treat PPH utilizing
vacuum induced uterine tamponade has emerged as an effective therapy. We have developed a novel system
that is specifically designed to tackle the numerous challenges of limiting blood loss, improving visualization,
restoring and maintaining uterine tone and quantifying blood loss in cesarean sections. The aim of this Phase
1 is to finalize design parameters, materials validation, and functional performance testing. A successful
Phase 1 will lead to the execution of an early feasibility trial.

Public health relevance
Project Narrative Postpartum hemorrhage (PPH) remains one of the leading causes of maternal morbidity and mortality worldwide. Despite advancements in other medical specialties, innovations in maternal health are lagging and the need for effective, rapid, and accessible interventions for PPH is urgently needed. Lucie Medical is developing a device to prevent hemorrhage and limit blood loss in cesarean sections.